Phthalate Exposure and Mechanisms of Action in the Neonatal Intensive Care Unit

PROJECT SUMMARY
Each year in the United States, over 300,000 newborns are admitted to a neonatal intensive care unit (NICU),
where they are exposed to a chemical-intensive hospital environment. The majority of NICU inpatients are
admitted for management of prematurity. In the NICU, infants face treatments that convey high-dose exposure
to phthalates, a family of ubiquitous endocrine-disrupting organic chemical plasticizers, during a life stage
equivalent to the third trimester of in utero development. We know that elevated exposure to phthalates during
the same in utero developmental window can result in suboptimal neurobehavioral, growth, and pulmonary
outcomes among term-born children. Past research shows that preterm infants are also at significant risk of
adverse multisystem outcomes potentially impacted by early life phthalate exposure. Our group has spent the
past decade investigating the contribution of in-hospital phthalate exposure to adverse outcomes among
preterm infants. Through robust epidemiological studies, we have demonstrated that NICU-based phthalate
exposure alters the trajectory of neurodevelopment and weight gain during the preterm period. Emerging data
indicates that phthalate exposure may contribute to the development of chronic lung disease of prematurity.
Yet many fundamental questions remain about the pharmacokinetics of phthalate metabolism in preterm
infants, specific care practices that confer phthalate exposure, and the mechanism of action of major phthalate
species in preterm infant disease. We propose to address these questions through the following Specific Aims:
Aim 1. Determine the pharmacokinetic profile of common phthalate diesters and their
monoester metabolites in neonates of varying postmenstrual and chronological ages using
the “natural experiment” of blood transfusion as a sentinel intravenous exposure.
Aim 2. Test five commonly used respiratory circuits to determine the relative phthalate
exposure conveyed by each.
Aim 3: Use a rodent model to examine the effects of inhalational phthalate exposure on the
pathobiology of chronic lung disease of prematurity.
The proposed study will provide actionable data that can rapidly translate into improvements in NICU practice
and facilitate future clinical investigation.

Public health relevance
Each year in the United States over 300,000 preterm infants are admitted to neonatal intensive care units (NICUs) where they are exposed to a chemical-intensive hospital environment. Phthalates, ubiquitous organic chemicals present in medical equipment, are common NICU-based exposures that have been associated with adverse outcomes in preterm infants. Phthalate Exposure and Mechanisms of Action in the Neonatal Intensive Care Unit will examine fundamental questions about the pharmacokinetics of phthalate metabolism in preterm infants, specific NICU practices that confer phthalate exposure, and the mechanism of action of major phthalate species in an animal model of preterm infant lung disease.